Outcomes after Hospital Discharge to Home Versus Discharge to a Facility for Older Patients with Alzheimer’s Disease and Alzheimer’s Disease Related Dementias

Project Summary
As adults age, they are much more likely to be hospitalized. Of those hospitalized, 2 in 5 receive rehabilitative
post-acute care, often at home or at a facility. Patients and caregivers predominantly prefer home-based care,
but half of hospitalized older patients receiving post-acute care received such care at a facility. Patients with
Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD), who are even more likely to be
hospitalized as patients without AD/ADRD, also prefer home-based care, but they are half as likely as patients
without AD/ADRD to be discharged home. Therefore, the decision of whether to discharge a patient to home
versus to a facility is an important one for older patients—including older patients with AD/ADRD—and their
caregivers. Our long-term goal is to provide rigorous evidence on outcomes of home-based versus facility-
based care. Research comparing outcomes by discharge destination, however, has been largely stymied by
the issue of confounding by indication. Since patients who are discharged home tend to be healthier than those
discharged to facilities, comparisons between the two groups are challenging. To address this issue, our
proposed work will employ a novel research strategy: we will use differences in the influence of physical
therapists (PTs) on the discharge destination as a “randomizing device” for a patient’s discharge destination.
This research strategy requires the inpatient PT’s identity, which is not contained in commonly-used large
claims datasets. By using Veterans Affairs (VA) electronic health record data, we can bring this novel research
strategy to bear across almost 100 VA hospitals. This allows us to answer the fundamental question of who
benefits or may be harmed by a discharge to home versus to a facility in a rigorous manner on a nationwide
scale. Under this research strategy, we can measure outcomes after discharging to home versus to a facility
for patients we call “on the cusp” between home and facility, for whom different PTs might come to a different
discharge destination recommendation (i.e., patients whose discharge destination might change based on
which inpatient PT they are assigned to). These patients, for whom discharge recommendations are uncertain,
would particularly benefit from better evidence on the benefits or harms of discharging to home. We propose 3
Aims: (1) examine outcomes, such as re-hospitalization and costs, after being discharged to home versus to a
facility, both for older patients with AD/ADRD and for older patients overall; (2) examine characteristics that
distinguish patients for whom different PTs may come to different discharge recommendations and identify
characteristics of patients with particularly better or worse health outcomes when going home versus to a
facility after hospitalization; and (3) perform qualitative interviews of inpatient PTs to better understand the
factors they take into account when seeing patients for whom the recommendation may not be clear-cut, and
how these factors may differ for patients with AD/ADRD. Our project will produce evidence for hospitals, health
care organizations, and policymakers on discharge decision-making and discharge planning for older adults.

Public health relevance
Project Narrative After a hospitalization, patients predominantly prefer home-based care, which makes the decision of whether to discharge a patient to home versus to a facility an important one for older patients, including those with Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD). Research comparing outcomes by discharge destination has been stymied by the issue of confounding by indication; to address this issue, our proposal will employ a novel research strategy: we will use differences in the influence of physical therapists on the discharge destination as a “randomizing device” for a patient’s discharge destination. Our project will produce rigorous evidence that will help guide decisions on where to discharge older patients after hospitalization—a decision monumental to patients, caregivers, hospitals, health care organizations, and policymakers.